Administrative Core

PROJECT SUMMARY
Core C: Administrative core
An Administrative Core is proposed to support the administrative needs of the Program Project Grant. The major
functions of the Core will be to provide a structure for decision making, organization of regular PPG meetings,
mechanisms for internal and external advice and review, and effective utilization of resources. This Core will be
Co-Directed by Drs. Glass and Witztum. Dr. Glass, Dr. Witztum, Dr. Evans, Dr. Loomba and Dr. Benner (PIs of
Projects 1, 3, 2, and Core B respectively) will form an executive committee for routine decision making. An
internal advisory committee consisting of Dr. Nicholas Schork, Dr. Alan Saltiel and Dr. Tatiana Kisseleva will
provide both administrative and scientific advice. An external advisory group will be constituted to review the
scientific program on an annual basis. The external advisory group will be selected to include expertise in NASH,
atherosclerosis, inflammation, gene expression and statistics. The Administrative Core will be responsible for
ensuring that the PPG conforms to the Resource Sharing Plan, the Sharing of Model Organisms and the Data
Sharing Plan. The Administrative Core will also be responsible for preparation of the Annual Non Competing
renewal.